Molecular probes for targeting facilitative fructose transporters (GLUTs) in biochemical and biomedical applications

PROJECT SUMMARY
The primary goal is to advance the development of GLUT-targeting molecular probes to facilitate the
characterization of cells and discrimination between cancer and normal cells. High sugar uptake has long been
identified as a hallmark of cancer. Recently, the specific dependence of cancers on fructose for development
and progression outlined fructose uptake as a potential diagnostic and therapeutic target. Respectively, changes
in the activity of facilitative fructose transporters (GLUTs) and alterations in the overall GLUT profile between
normal and metabolically compromised cells have set the foundation for developing GLUT-based approaches to
target cancer cells. However, specific targeting of disease-relevant fructose GLUTs remains a challenge, limiting
the use of GLUTs in diagnostic and therapeutic applications. The proposed research program demonstrates the
targeting of selected fructose GLUTs (GLUT2, GLUT12, and GLUT5) for identifying fructose-dependent cells in
imaging applications. The proposal addresses several challenges in developing GLUT-specific molecular
probes, GLUT-targeting cell imaging, and GLUT activity screening approaches. The primary innovative
component enables discrimination between nonspecific fructose GLUTs allowing for designing specific
molecular probes for several cancer-relevant fructose transporters. The developments proposed in this research
include approaches for GLUT-based cell profiling, GLUT-based characterization of cancer cells, and GLUT-
based in vivo imaging. The direct outcomes of this research include the validation of a novel multi-color multi-
GLUT screening approach for measuring GLUT5:GLUT2 activity ratios through fluorescence and novel turn-on
fluorescent molecular probes for real-time monitoring and high-throughput fluorescence screening of GLUT
activity. The project will yield a new GLUT-based characterization of different breast cancer cell lines and identify
the fructose-dependent cell lines potentially targeted for in vivo imaging by GLUT-specific probes. The project
also advances the specific targeting of fructose GLUTs in vivo by developing GLUT-specific imaging probes for
PET applications. The research project is designed to be carried out primarily by undergraduate students under
the supervision of the PI and a graduate researcher. The program provides a comprehensive multidisciplinary
educational platform for undergraduate and graduate researchers and offers a hands-on research experience at
the interface of chemistry and biology. By engineering probes that can specifically target other fructose or glucose
transporters, we will advance to fingerprinting GLUTs to characterize and distinguish cells. GLUT-specific probes
will enable fundamental studies to foster an understanding of the impact of each GLUT and different dietary
sugars at the molecular level on health and disease.

Public health relevance
PROJECT NARRATIVE Alterations in sugar uptake and activity of facilitative sugar transporters – GLUTs - arise as a biomarker of metabolic diseases, such as obesity, diabetes, and cancer. Understanding the differences, the composition, and activity of GLUTs between cells provides the grounds for distinguishing cell types and subtypes and for more accurate detection of metabolically compromised cells. The current research established GLUT-specific fluorescently-labeled molecular probes for application in biochemical and biomedical research and cancer detection.